CoVPN LOC Cross-Protocol Infrastructure Supplement for GY15 and GY16

NOSI: NOT-AI-20-034
FOA: PA-20-135 – Emergency Competitive Revision to Existing NIH Awards
Activity Code/Award: UM1/A1068614-15 (parent award)
------------------------------------------------------------------------------------
Project Abstract
Given the rapid spread of SARS-CoV-2 infection, the on-going global pandemic, and the risk for seasonal
recurrence there is a critical need to continue work begun in several COVID-19 vaccine efficacy trials, perform
necessary bridging studies for select populations, and continue to study the immunological effects of SARS-
CoV-2 in an evolving epidemic landscape. Due to its experience in implementation of global HIV vaccine
efficacy trials and its operational capacity to respond to a new global pandemic, the HVTN has been chosen as
the vaccine operations center for the newly constituted COVID-19 Prevention Network (CoVPN). Continuing
work begun in the spring of 2020 in a series of large scale efficacy trials, this proposal outlines four specific
aims required to support the infrastructural capacity to continue this work over the coming months: to support
the CoVPN vaccine operations center for implementation and management of COVID-19 vaccine phase 3
efficacy and bridging trials, to rapidly publish trial data, to build external relations networks in high-risk groups,
and to work with media outlets to advertise and promote ongoing enrollment. This proposal will ensure that 74
clinical trials sites in the United States and over 50 trial sites in Latin America and Sub-Saharan Africa are fully
support in continuing implementation of NIH supported COVID-19 vaccine efficacy trials and bridging studies
planned for implementation over the next year.

Public health relevance
NOSI: NOT-AI-20-034 FOA: PA-20-135 – Emergency Competitive Revision to Existing NIH Awards Activity Code/Award: UM1/A1068614-15 (parent award) ------------------------------------------------------------------------------------ Project Narrative The outbreak of SARS-CoV-2 across the globe presents an unprecedented health and economic challenge to the worlds’ population, one that may not be ameliorated until effective vaccines penetrate to the majority of the population, including in high risk and immunocompromised persons, across the globe. The CoVPN is dedicated to this task and will work together with the pharmaceutical industry to implement efficacy and bridging trial in our target regions in the US, Latin America, Africa, and Asia. In this proposal, the HVTN, working as the CoVPN vaccine operations center, will support the operational and clinical site capacity necessary to continue to implement trials in both the US and in international sites.